Slo2 channels in Olfactory Adaptation

Project Summary
Sensory adaptation is an important feature of all sensory systems, as it allows them to maintain sensitivity
over a wide range in backgrounds of varying stimulation. Here, we introduce Na+-activated K+ (KNa/Slo2)
channels a new player to the mechanisms that underlie sensory adaptation. Studies over the years have
suggested that KNa/Slo2 channels might function to dampen activity in states of excessive excitation. KNa/Slo2
channels are unique in that the major depolarizing ion, Na+, activates a repolarizing K+-selective pore; thus by
nature, these channels seem designed to be a built-in hyperpolarizing mechanism against episodes of excessive
excitation. In the proposed studies, we use Drosophila as a model system in which to genetically manipulate
dSlo2 expression, test for olfactory adaptation in vivo, identify the cells and subcellular domains in which dSlo2
channels affect adaptation, and electrophysiologically examine the role of dSlo2 channels in the excitability of
these cells.

Public health relevance
Project Narrative Na+-activated K+ (KNa)/Slo2 channels are unique in that an influx of excitatory Na+ ions can lead to the activation of these repolarizing K+ channels that can then serve to dampen excitation. While their biophysical properties are well studied in heterologous systems, little is known about the roles KNa/Slo2 channels play in vivo. Proposed studies will examine a newly identified role for KNa/Slo2 channels in olfactory adaptation, and results will inform our basic understanding of how sensory neurons can maintain sensitivity in the face of changing background stimulation.